Determining the Role and Targeting potential of Serine Metabolism in aggressive sub-types of Acute Myeloid Leukemia

Project Summary/Abstract (30 lines max):
Acute myeloid leukemia (AML) is an aggressive blood cancer that currently ranks as the deadliest form
of leukemia in both adults and children. These unsatisfactory outcomes highlight the urgent need to develop
more-effective therapies that either replace or improve the effectiveness existing chemotherapies.
Metabolic pathways that regulate the synthesis and catabolism of the non-essential amino acid, serine
have recently emerged as therapeutic vulnerabilities in several different types of human cancer. We and others
recently discovered that certain aggressive sub-types of AML, such as those bearing MLL-rearrangements
(MLLR) or internal tandem duplications of the FLT3 genes (FLT3ITD) heavily depend on serine to maintain cell
cycling and the differentiation blockade. Specifically, we found that restriction of dietary serine significantly delays
disease onset in a mouse model of MLLR-AML, while others have shown that chemical inhibition of serine
synthesis impedes MLLR- or FLT3ITD-AML. This proposal aims to address 3 key unanswered questions:
1) How is serine utilized to support AML? Our preliminary data suggest that AML cells utilize serine to
supply pools of purines and purine-derivatives such as S-adenosylmethionine (SAM), which are key anabolic
precursors needed to drive cell proliferation and maintain gene expression programs, respectively. We will use
a combination of metabolomics, transcriptomics and proteomics in genetically engineered mouse (GEM) and
patient-derived xenograft (PDX) models of AML to precisely determine how serine is utilized to support AML.
2) What serine-regulatory enzymes support AML and why? Although several enzymes contribute to
serine metabolism, we have identified MTHFD2 as a particularly important candidate in AML. Specifically, we
have seen that MTHFD2 inhibition promotes the terminal differentiation of MLLR-AML cells and furthermore,
MTHFD2 is the most frequently over-expressed enzyme in human cancer. We have now obtained mice bearing
floxed alleles of murine Mthfd2, which we will use to determine the importance of Mthfd2 in AML and healthy
hematopoiesis. Given that MTHFD2 catalyzes the incorporation of serine-derived carbons into newly synthesized
purines and SAM, we will also examine how Mthfd2 deletion impacts purine and SAM levels as well as the
downstream cellular processes supported by these metabolites, such as proliferation and gene expression.
3) Can we develop effective serine-targeting therapies in AML? To address this question, we will evaluate
therapeutic strategies for limiting serine availability (e.g. simultaneously restricting dietary serine and serine
synthesis) or chemically targeting MTHFD2 using liposomal nanoparticle technology in mouse models of AML.
Collectively, the results of these studies will provide new insights into the role of serine metabolism and
potentially establish a foundation for developing novel therapeutic strategies for the treatment of AML. Moreover,
serine metabolism is often deregulated in many tumor settings and thus results from our proposed studies will
likely have implications for other forms of human cancers.

Public health relevance
Relevance to Public Health (2-3 sentences): Annually, approximately 1 in 12,500 Americans are newly diagnosed with acute myeloid leukemia (AML) and over 12,000 die from the disease. The overall survival rate of AML patients is below 25% for adults and 70% for children and these poor outcomes are largely due to high rates of resistance to the current standard of care treatments and disease relapse. The aim of this proposal is to identify the molecular underpinnings of AML pathogenesis and therapy resistance to develop more effective therapeutic strategies.